Toward a Universal Influenza Virus Vaccine

OVERALL PROJECT SUMMARY
Influenza viruses continue to pose a significant threat to global public health. Consequently, there is a vitally
important need to generate new influenza virus vaccines and innovative vaccination strategies. The
development of a long-lived broadly-protective influenza virus vaccine would have a tremendous impact on
worldwide efforts to control influenza viruses. The purpose of this renewal is to continue on our efforts to
address this need. Since the initial funding of this Program we have made major advances in our knowledge of
the human immune response to influenza viruses and in our understanding of a unique class of broadly-
neutralizing antibodies. We discovered new mechanisms for virus neutralization in vivo by antibodies that
recognize conserved regions of the hemagglutinin glycoprotein, made new discoveries regarding B-cell
induction and persistence of humoral immunity in humans, and crucially, generated novel vaccine immunogens
and immunization regimens. Through this work, we have elucidated new paradigms in influenza vaccination
that we plan to advance further by continuing our long established research collaboration. To achieve this, we
will improve the ability of our hemagglutinin immunogens to induce antibodies with optimal effector functions.
We will examine the induction and maintenance of long-lived plasma cells and use this information to identify
potent B-cell adjuvants that promote long-lasting immune responses. Moreover, we will look to explore the viral
neuraminidase as a target of broadly neutralizing antibodies; this surface glycoprotein has the potential to
improve the overall breadth and immunogenicity of a universal vaccine. This approach will be combined with
parallel efforts to generate universal stalk-based vaccines for group 2 influenza A HAs and also influenza B
viruses. These findings will be translated into animal models of influenza and supported by reagents from our
highly sophisticated mAb Core. Given our accomplishments in the previous funding period and the combined
expertise of the collaborating investigators, we strongly believe that our continued efforts will advance the
generation of broadly-protective vaccines which are truly universal in providing protection against group 1,
group 2 and influenza B viruses.

Public health relevance
OVERALL PROJECT NARRATIVE The purpose of this proposed collaborative work is to further advance the development of long-lasting, broadly protective universal influenza virus vaccines which will be achieved by integrating comprehensive studies of human humoral immunity following vaccination or natural infection, state-of-the-art techniques in monoclonal antibody production, use of gold-standard animal models and novel design of vaccine immunogens which refocus humoral immunity to immunosubdominant but conserved influenza virus epitopes. Our success in the past funding period led to novel discoveries which have resulted in several vaccine candidates advancing to Phase I clinical studies and highlighted several exciting new research directions which warrant further investigation. We believe that support of this highly collaborative P01 will result in the identification of new correlates of protection for influenza virus vaccines, will significantly advance the field and bring us closer to producing a truly universal influenza virus vaccine capable of protecting against group 1 and 2 influenza A and B viruses.